Longitudinal Development of Attention-Related Brain Networks from Birth to School-Age and Risk for Anxiety Disorders

Anxiety disorders are the most common pediatric psychiatric illness, affecting up to 30% and severely
impairing up to 20% of all youth prior to age 18. Unfortunately, up to 50% of children remain symptomatic even
with the best available treatment, making anxiety disorders a major public health problem. Clarifying how the
brain develops differently in children who end up developing an anxiety disorder could help us devise new,
more effective treatments based on correcting or preventing these underlying brain differences. Prior studies
had indicated that anxiety disorders are associated with changes in a part of the brain that directs attention to
new, unexpected stimuli (the “ventral attention network”, VAN) and in a part of the brain that is involved in
staying focused on current goals and not being distracted (the “fronto-parietal network”, FPN). Problems in the
VAN and FPN may decrease the ability of individuals with anxiety disorders to maintain attention on current
goals and cause them to instead be distracted by new stimuli that are interpreted as threatening. Work from
the original grant (which this current renewal proposes to extend) indicated for the first time these VAN and
FPN changes are present in neonates (age < 6 weeks) at high risk for developing an anxiety disorder based on
family history or observed infant behaviors at age 1 year. Thus, the altered brain development associated with
developing an anxiety disorder may start already by the time of birth. The goal of this proposed renewal is to
continue to track the infants from the original study at two more visits: at preschool (3-5 years) and at school-
age (6-8 years), thus being able to track how the brain continues to develop up until the time when many of
these children are expected to have developed anxiety disorders. At each visit, we will use brain scans to
measure VAN and FPN function, perform psychiatric interviews to determine whether an anxiety disorder is
present, and observe how parents and children interact together in challenging situations (like doing a hard
puzzle together). The goals of the study are to learn (1) how the VAN and FPN develop from birth to age 8
years, (2) how the VAN and FPN develop differently in children who end up having an anxiety disorder, and (3)
to learn if there are specific types of interactions between children and their parents that are associated with
changes in the VAN and FPN and in the child developing anxiety. Past work has shown that when parent-child
interactions include a lot of “parental overcontrol” in which parents are highly controlling, the children are more
likely to develop problems with anxiety. Overall, this study represents a time-limited opportunity to follow a
group of children from birth up until the age by which many of them are likely to develop an anxiety disorder.
Using the results of this study, we hope in future work to design new strategies that might prevent changes in
the VAN and FPN and thus reduce risk for children to develop anxiety disorders. These strategies could
include teaching parents and children how to interact in challenging situations to minimize parental overcontrol
or training children to stay focused and avoid distractions by new, unexpected stimuli.

Public health relevance
Anxiety disorders are the most common form of mental illness, can be highly impairing, and behaviors and brain changes that are precursors of anxiety disorders might start as early as birth. The goal of this study is to track the development of parts of the brain involved in directing attention starting from shortly after birth (age < 6 weeks) through school-age (6-8 years) and test whether patterns of brain development predict which children develop problems with anxiety by school-age. The results of this study are likely to assist in the early identification of children who might develop problems with anxiety and could lead to the design of interventions that lower the risk for developing anxiety.